IVIS Spectrum CT imager for the Medical College of Wisconsin

SUMMARY ABSTRACT
We request funds to purchase a new IVIS Spectrum-CT instrument equipped with a thermoelectrically-cooled
CCD camera, integrated optical and micro-CT sources and detectors, and 3D diffuse tomographic reconstruction
software. The system includes bioluminescent and fluorescent phantom mouse software and a rodent
anesthesia system. This instrument will be installed in the Biomedical Imaging Shared Resource (BISR) facility
at the Medical College of Wisconsin (MCW). Since its creation in 2004, the BISR has supported the biomedical
research programs of a diverse group of NIH-funded investigators at MCW and its partner institutions in the
Clinical and Translational Science Institute (CTSI) of Southeastern Wisconsin. Consistent with its record of major
investments in medical and biomedical imaging instrumentation and facilities, MCW has committed substantial
matching funds to purchase the maintenance contract and provide technical support for the instrument. The IVIS
Spectrum-CT provides 2D and 3D quantitative bioluminescence and multispectral fluorescence with low dose
computed tomography (CT), spectral unmixing, and Cerenkov imaging currently unavailable in the obsolete
optical and micro-CT instruments existing at MCW.
Access to the requested fully integrated optical and micro-CT imaging platform will markedly benefit the research
projects of eight federally funded (NIH, DOD) Major User investigators and four Minor User investigators as
described in this application. These projects will benefit from the requested instrumentation thanks to increased
resolution and sensitivity; spatial co-registration across imaging modalities; and the repeatable, non-invasive and
minimally-ionizing examination that enables longitudinal imaging to track disease pathogenesis and treatment
responses in rodent models. When installed, this instrument will be the only multimodal 3D imaging instrument
for in vivo small animal imaging in Milwaukee and southeastern Wisconsin.
The BISR is already equipped with the infrastructure and manned by the support staff required for installation
and expert operation of the IVIS Spectrum-CT. The new instrument will be maintained by personnel experienced
in operating and maintaining in vivo rodent imaging instrumentation, small animal anesthesia, and managing a
multi-user recharge facility. Instrument time will be allocated using the existing BISR scheduling system
implemented in iLabs. A standing local advisory committee will provide oversight. BISR financial operations are
managed by the senior business administrator in the MCW Cancer Center. Acquisition of the IVIS Spectrum-CT
instrument requested in this application will have a profound impact on NIH-funded biomedical research
programs at MCW and its partner CTSI institutions.

Public health relevance
PROJECT NARRATIVE The Medical College of Wisconsin (MCW) is a nationally prominent freestanding medical school with an established reputation for leading-edge imaging experimentation in support of research programs in inflammation; cancer; diabetes; and cardiovascular, digestive, kidney and infectious diseases. The Biomedical Imaging Shared Resource (BISR) is the foundation for in vivo small animal imaging at MCW. Access to the state- of-the-art multi-modal 3D optical and micro-CT imaging instrument requested for the BISR in this application will elevate and contribute directly to the research and medical education missions of MCW and its partner institutions in the Clinical and Translational Science Institute of Southeastern Wisconsin.